WORKER HEALTH AND SAFETY TRAINING

The primary aim of this program is to provide high quality occupational safety and health training to three populations: (1) Teamsters construction workers involved in the cleanup of uncontrolled hazardous waste sites (i.e., "Superfund" sites); (2) Teamsters working at Resource Conservation and Recovery Act (RCRA) Operations - Treatment, Storage, and Disposal (TSD) facilities; and (3) Teamsters in the transportation industry who may be exposed to hazardous materials as a result of spills or leaks that occur during transport or loading, unloading, and handling of cargo at truck terminals and loading docks. The training for groups 1 and 2 will insure that these workers possess the technical knowledge and skills required to work safely on hazardous waste sites and at treatment, storage, and disposal facilities. The training for group 3 will insure that transportation workers who may witness hazardous material spills are aware of the health effects associated with exposures to hazardous materials, know how to identify hazardous materials, and understand that they must receive extensive training prior to engaging in clean-up of such spills.